Structural and functional understanding of bacterial defense and viral counter defense

Project Summary
Viruses that infect bacteria and archaea are the most diverse and abundant biological agents on the planet.
The selective pressures imposed by these ubiquitous viral predators has a profound impact on the
composition and the behavior of microbial communities in every ecological setting. To fight off these viral
predators, microbes have evolved diverse defense mechanisms to protect themselves from viral infections.
Despite the rapid progress in this still nascent field, there are still many blind spots in our basic understanding
of bacterial immunology and the relationship of these immune systems to those preserved in eukaryotes. The
intent of this supplemental is to solicit funds to replace our current liquid chromatography system. This system
is now out of service. The new liquid chromatography system will be used to support projects aimed at using
biochemical and structural methods to understand bacterial immune systems and the relationship of these
systems to the immune systems in eukaryotes.

Public health relevance
Project Narrative Microbes have evolved diverse defense mechanisms to protect themselves from viral infections and understanding the mechanisms of these immune systems has resulted in transformative new innovations for treating disease in humans. The intent of this supplemental is to replace our current liquid chromatography system, which is used daily and has been necessary for the structural and biochemical studies that help explain mechanisms.